THE ROLE OF NEUTROPHILS IN REGULATING DISEASE SEVERITY OF VIRAL SEXUALLY TRANSMITTED INFECTIONS

PROJECT SUMMARY
Herpes simplex virus-­2 (HSV-­2) is the major causative agent of genital herpes, an incurable sexually
transmitted infection that disproportionately infects women and poses a global health burden. Genital herpes is
associated with recurrent symptoms that lead to tissue damage in the genital tract, and this pathology has
been proposed as a mechanism for increased susceptibility to other viral sexually transmitted infections such
as human immunodeficiency virus (HIV)2,3. The cellular and molecular mechanisms that lead to inflammation
and tissue damage within the female genital tract during HSV-­2 infection are poorly understood. Neutrophils
are highly destructive innate immune cells that patrol the vagina at the steady state4. The role of neutrophils
during viral sexually transmitted infections is not well defined. Our data show that neutrophils drive a
pathogenic response against HSV-­2. Depletion of neutrophils prior to infection resulted in significantly
attenuated disease severity and tissue damage without affecting viral titers, suggesting that immunopathology
plays a key role in genital herpes. Neutrophils are capable of multiple effector functions, including cytokine
secretion. After neutrophil depletion, there was a profound reduction in IL-­1b levels in the vagina, and the
majority of IL-­1b expressing cells in the vagina after HSV-­2 infection were neutrophils, suggesting that
neutrophil-­mediated disease during HSV-­2 infection may be driven by this pleiotropic pro-­inflammatory
cytokine. A multitude of factors can activate the neutrophil response, including virus-­ and bacteria-­derived
products. Transient perturbation of the vaginal microbiota led to an increase in neutrophil numbers in the
vaginal tissue, suggesting that vaginal bacteria may play a role in regulating neutrophil-­dependent tissue
damage during genital herpes. Together, this proposal aims to dissect the mechanisms of neutrophil activation
and identify the key factors that drive neutrophil-­dependent tissue damage and inflammation at the vaginal
mucosa during HSV-­2 infection. The requirement of IL-­1b produced by neutrophils in driving genital
inflammation will be assessed in vivo using knockout models and cytokine neutralization, and downstream
effector mechanisms that may lead to mucosal permeability will be examined. The role of the vaginal
microbiota in regulating pathogenic neutrophil responses will be tested by transient introduction of common
vaginal bacteria into mice. Finally, CRISPR/cas9 will be used to delete candidate pattern recognition receptors
in neutrophils derived from Hoxb8-­transformed progenitor cells to identify pathways that can stimulate
neutrophils during genital HSV-­2 infection. Greater understanding of the pathology caused by neutrophil
responses to HSV-­2 infection may provide new targets for therapeutics that can reduce symptoms, tissue
damage and susceptibility to other viral sexually transmitted infections.

Public health relevance
PROJECT NARRATIVE Herpes simplex virus- 2 (HSV- 2) causes genital herpes, an incurable sexually transmitted infection that accounts for a significant amount of morbidity worldwide. Inflammation and tissue damage caused by genital herpes may increase susceptibility to other viral sexually transmitted infections such as human immunodeficiency virus (HIV). This proposal aims to dissect the mechanisms by which pathogenic neutrophil repsonses in the vagina mediate inflammatory damage during genital HSV- 2 infection and the factors that regulate these responses.